A systems biology approach to identify cortical and medullary gene regulatory networks related to Hypoxia Inducible Factor-1A

ABSTRACT
Acute Kidney Injury (AKI) is a common and costly complication in hospitalized patients, which is associated
with high mortality. Many episodes of AKI are due to episodes of hypoxia, and cells in the kidney medulla are
particularly susceptible to hypoxic injury. Hypoxia Inducible Factor-1A (HIF1A) is a key transcription factor
regulating the response to hypoxia. While HIF1A has been well characterized, it is still poorly understood how
the target genes of HIF1A are regulated in a physiologically low oxygen environment, such as the kidney
medulla. Preliminary data from percutaneous kidney biopsies sampling mainly the kidney cortex of individuals
show that HIF1A target genes exhibit cell type enrichment. Transcription factor cooperativity may explain cell
type enrichment and in silico promoter analysis predicted transcription factors that co-modulate with HIF1A in
the promoter region. To expand upon these findings, this project proposes to use multiome data from the
Kidney Precision Medicine Project to validate that the predicted transcription factor motifs are located in areas
of open chromatin (Aim 1A). We will additionally generate multiome data from kidney samples that are
sectioned into cortical and medullary regions. This project then aims to identify the gene regulatory network for
the kidney cortex and medulla with respect to HIF1A (Aim 1B). As adaptive cell states are associated with
poor long-term outcomes, we will then identify aspects of the gene regulatory network that are perturbed in
adaptive cell states by identifying nodes of the network with differentially accessible chromatin between healthy
and adaptive cell states (Aim 2). These data will provide important insight into how HIF1A target genes are
differentially regulated in kidney cortex and medulla and identify epigenetic alterations that may contribute to
maladaptive repair after an episode of Acute Kidney Injury.

Public health relevance
PROJECT NARRATIVE Acute Kidney Injury (AKI) is a common and deadly complication in hospitalized patients, and many episodes of AKI are due to episodes of low oxygen supply. Kidney cells located in the medulla are particularly susceptible to AKI. This project aims to understand how Hypoxia Inducible Factor-1A (HIF1A), a key transcription factor regulating the response to low oxygen, is regulated in the kidney medulla.